Polycomb-mediated heterochromatin formation in Tetrahymena

DESCRIPTION (provided by applicant): Polycomb group (PcG) proteins are important epigenetic regulators of transcription repression and have long been under active investigation for their roles in Hox gene regulation, X-inactivation, and tumorigenesis in Drosophila and mammalian systems. Recent findings that PcG proteins are conserved in Tetrahymena make it possible to address some of the fundamental mechanisms of Polycomb repression with powerful genetic and biochemical tools available in the unicellular model system. Developmentally regulated heterochromatin formation occurs during the germline-somatic differentiation in Tetrahymena. It has been established that this is an RNAi-dependent PcG-mediated pathway. The proposed studies will explore the mechanism by which the PcG proteins are recruited by RNAi machinery, a mechanism likely to be conserved in higher eukaryotes. We will also examine the potential crosstalk between H3K27 methylation and H2A ubiquitylation, two conserved epigenetic marks deposited by PcG proteins. In particular, we will assess their concerted functions in transcription repression and probe the underlying mechanism. The proposed studies will significantly advance our knowledge for the function of PcG proteins in genome organization and transcription repression. Given that PcG proteins play critical roles in stem cell pluripotency, cell differentiation, and cell malignancy, the proposed studies will also have important implications in public health, including disease diagnosis and treatment. The project matches with the mission of the National Institute of General Medical Science (NIGMS) and is budgeted at $1,250,000 for a five-year period.

Public health relevance
PUBLIC HEALTH RELEVANCE: Project Narrative Polycomb group proteins are involved in stem cell pluripotency, cell differentiation, and cell malignancy. The proposed studies will significantly advance our knowledge for the underlying mechanism, particularly the function of PcG proteins in genome organization and gene repression. This will have important implications in public health, including disease diagnosis and treatment. Project Narrative Polycomb group proteins are involved in stem cell pluripotency, cell differentiation, and cell malignancy. The proposed studies will significantly advance our knowledge for the underlying mechanism, particularly the function of PcG proteins in genome organization and gene repression. This will have important implications in public health, including disease diagnosis and treatment. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Histone modifications directly affect the structure and organization of chromatin, and serve as an important epigenetic mechanism for transcription regulation in eukaryotic cells. In particular, Polycomb group (PcG) proteins deposit specific histone modifications, regulate heterochromatin formation, and maintain the cellular memory for transcription repression. The mechanism of Polycomb repression is only beginning to be revealed by the rapid progress in chromatin biology. Initially identified for their roles in Hox gene regulation in Drosophila, PcG proteins now feature a widely-expanded list of target genes in higher eukaryotes, and are implicated in the regulation of cell differentiation and stem cell renewal processes, as well as mis-regulation in various cancers. Unexpectedly, PcG protein homologues were found in several recently sequenced unicellular model systems, including Tetrahymena, pointing to their ancient origin. Our studies show that Polycomb repression underlies the developmentally regulated heterochromatin formation and DNA elimination in Tetrahymena. Current evidence in Tetrahymena delineates a pathway recapitulates key features of Polycomb repression in higher eukaryotes, starting from transcription of non-coding RNAs (ncRNAs) and generation of piRNA-related small RNAs (scnRNAs), followed by RNAi-dependent recruitment of the specific histone methyltransferase (the Ezl1p complex) and deposition of heterochromatic histone marks (H3K27 and H3K9 methylation), and eventually leading to binding of the specific chromo domain effectors (Pdd1p and Pdd3p) and repression of transcription. However, critical connections that will allow the integration of transcription, RNAi and Polycomb repression into one pathway are still missing. Using Tetrahymena as the model system, our proposed studies will dissect the pathway with a combination of genetic, biochemical and cell biology approaches. Specific aims of the proposal are to: Aim 1 Study physical interactions that integrate transcription, RNAi and Polycomb repression. 1-1 Characterize protein-protein interactions connecting transcription machinery, RNAi machinery and PcG proteins. 1-2 Study in vivo association of ncRNAs/ scnRNAs with transcription machinery, RNAi machinery and PcG proteins. Aim 2 Characterize genetic interactions that integrate transcription, RNAi and Polycomb repression. 2-1 Genetically dissect the role of the nuclear cap-binding complex (CBC) and Ars2p in RNAi and Polycomb repression. 2-2 Characterize genetic interactions important for robust heterochromatin formation 2-3 Study transcription repression by the RNAi components and PcG proteins Aim 3 Determine the structure-function relationship of the Ezl1p complex. 3-1 Reconstitute the Ezl1p complex. 3-2 Study direct physical interactions between ncRNAs and the Ezl1p complex. 3-3 Map minimal functional domains of the Ezl1p complex by genetic studies. 3-4 Define the structural basis for functional independency of Ezl1p and Ezl2p.